SK Current, beta-3 adrenoceptor activation and Sex Differences in Ventricular Arrhythmogenesis

Project Summary
The broad and long-term goal of this research project is to test the hypothesis that (1) the response of apamin-
sensitive small conductance Ca2+-activated K+ (SK) current (IKAS) to sympathetic stimulation plays an important
role in the mechanisms of sex differences in cardiac arrhythmogenesis and that (2) beta-3 adrenoceptor (AR)
activation is antiarrhythmic and eliminates the sex difference of IKAS activation during sympathetic stimulation.
In the current funding period, we discovered a significant sex difference of both the SK protein and IKAS at
baseline and that the magnitudes of sex differences are amplified during isoproterenol or acetylcholine
infusion. Apamin reduces the phase singularities (PSs) in ventricular fibrillation (VF) more effectively in the
female than in the male ventricles. It is unclear which AR is responsible for the isoproterenol-induced IKAS
activation. Isoproterenol activates the beta-1 and beta-2 ARs at lower concentrations than the beta-3 AR.
Contrary to the effects of beta-1 and beta-2 AR activation, beta-3 AR activation exerts negative inotropic
effects in the myocardium. Beta-3 ARs likely served as a buffer or rescuer of the excess catecholamines. We
showed in a canine model of ventricular tachycardia that BRL-37344 (a beta-3 agonist) is antiarrhythmic. We
hypothesize that beta-3 AR activation is antiarrhythmic and eliminates the sex difference of IKAS activation
during sympathetic stimulation in the rabbit model. Specific Aim 1: SK current, beta-3 adrenoceptor activation,
and Sex Differences in Ventricular Arrhythmogenesis. We will perform optical mapping and patch clamp
studies with specific beta-1 and beta-2 antagonists in the presence of isoproterenol. We also will perform
optical mapping studies to determine the effects of mirabegron on phase singularities (PSs) during VF with and
without isoproterenol. In additional experiments, we will use BRL-37344 instead of mirabegron to test the
hypothesis that this antiarrhythmic mechanism is a class effect shared by other beta-3 agonists. The
antiarrhythmic action of mirabegron will then be tested in a rabbit model of myocardial infarction. These
findings will be used to test the hypothesis that beta-3 AR activation rescues the proarrhythmic effects of beta-
1 and beta-2 stimulation, indirectly reduce IKAS, and eliminates the sex differences of PSs in VF. Specific Aim 2:
Na+-K+ ATPase (NKA) activation during beta3 stimulation contributes to the sex differences of antiarrhythmic
action. Beta-3 AR activates NKA, which may reduce Ca2+ overload-induced cardiac arrhythmias. We
hypothesize that NKA activation plays a vital role in the antiarrhythmic effects of beta-3 AR activation. We will
first perform studies to determine if there is a sex difference in beta-3 AR, NKA protein, and mRNA in rabbit
ventricles. Optical mapping studies will be done in the presence of ouabain, a specific NKA blocker, to
determine if the company of NKA is required for the antiarrhythmic effects of beta-3 activation. Rabbit
ventricular action potential models will be used for computer simulation studies to assess the importance of
NKA activation in the antiarrhythmic mechanisms of beta-3 AR activation.

Public health relevance
PROJECT NARRATIVE This research project will study the effects of sympathetic stimulation on cardiac ionic currents responsible for ventricular fibrillation, a lethal heart rhythm disorder. Because heart rhythm disorder is a major cause of sudden death, this study is clinically significant.